A Comprehensive Cell-Type-Specific Developmental Genetic Toolkit for the Drosophila Visual System

Project Summary (R21)
Neural progenitors produce an enormous diversity of neuronal and glial cell types to form a functional
nervous system. With the advance of single-cell genomic technologies, more and more cell types with distinct
transcriptomic signatures have been defined; yet there is a significant lack of genetic tools to identify, label, and
manipulate specific cell types for developmental and functional studies. To efficiently and reliably identify
useful GAL4 drivers expressed in a single cell type throughout development, we will take advantage of single-
cell mRNA sequencing (scRNA-seq) and single nucleus RNA/ATACseq data to produce GAL4/split-GAL4
lines that provide targeted genetic access throughout development to any and all optic lobe neurons.
Aim 1: Developing a collection of gene-specific split-GAL4 lines expressed in single cell types in the
developing optic lobe. Our scMarco pipeline allows us to identify marker gene pairs in scRNA-seq data whose
overlap selectively labels one specific optic lobe cell type. We will generate split-GAL4s inserted in these gene
pairs that reproduce the expression of the genes. Their overlap will generate cell-type specific drivers. We have
identified 123 genes to generate split-GAL4s hemi-drivers whose pair combinations can selectively target 81%
of all optic lobe cell types.
Aim 2: Using single-cell multiomics to identify enhancer fragments to generate cell-type-specific drivers.
The expression pattern of most genes is controlled by multiple enhancers that each regulate the same gene in
different cell types: These enhancers offer high cell-type-specificity. We will use our chromatin accessibility
single-cell multiomics (RNA+ATAC-seq) datasets to identify enhancers individually specific to almost any
neuron during development that will be cloned to generate GAL4 lines targeting these neuron types.
Aim3: Combining gene-specific and enhancer-based split-GAL4 lines for complete neuron coverage. As
not all cell types can be marked by a combination of gene specific split-GAL4 drivers or by specific enhancers,
we will combine the two approaches above to produce tools targeting all cell types in the optic lobe. We will
generate split-GAL4 lines with enhancer fragments that will be used in combination with the gene-specific-
split-GAL4 lines. This will provide the cellular morphology and thus the identity of the neuron throughout
development and will allow manipulation of their function of each neuron.
Altogether, this collection of developmental cell-type-specific driver lines will be a valuable resource to
study any cell type in the optic lobe, thus powering further developmental and functional studies. The gene-
specific split-GAL4 tools (Aim 1) can also be used in any tissue of Drosophila where single cell transcriptomics
is available, thereby expanding the power of this genetic approach to the whole fly community.

Public health relevance
Project Narrative (R21) Drosophila, with its genetic amenability and small brain size, yet sophisticated behavior, is a powerful model system to study how the diversity of neurons is generated and how circuits are built to control behavior. Taking advantage of single-cell mRNA sequencing and ATAC seq, it is possible to identify genes that are expressed in one or a few neurons as well as enhancer elements that are active in only one cell type. This allows the generation of GAL4 or Split GAL4 intersection driver lines that are expressed in a single neural type throughout development, thus allowing very precise developmental and functional studies.